Investigating the Impact of Load-Dependent and Structural Arterial Stiffness on Cerebrovascular Blood Flow in Individuals Post-Stroke

PROJECT SUMMARY/ABSTRACT
Individuals post-stroke exhibit significantly increased total arterial stiffness and reduced cerebral blood flow
compared to healthy age- and sex-matched peers. Increased total arterial stiffness and reduced cerebral blood
flow place individuals post-stroke at an elevated risk for recurrent stroke and cerebrovascular decline. An
emerging body of literature suggests that investigating the mechanisms which underly total arterial stiffness,
namely load-dependent and structural arterial stiffness, provides increased insight into how arterial stiffness
impacts cerebrovascular decline. However, there remains a clear lack of knowledge regarding how load-
dependent and structural arterial stiffness affect cerebrovascular blood flow in individuals post-stroke. A critical
need exists to evaluate the impact of structural and load-dependent stiffness on cerebrovascular blood flow
post-stroke, to allow for future interventions to be developed targeting a reduction in arterial stiffness and the
related cerebrovascular decline. The objective of this proposal is to determine the distinct impacts of load-
dependent and structural arterial stiffness on cerebrovascular blood flow at rest, and during a dynamic sit-to-
stand task, in individuals with stroke. For Aim 1, I hypothesize that structural arterial stiffness will be inversely
associated with resting cerebral blood flow, and load-dependent stiffness will be inversely associated with
resting cerebrovascular conductance, or the ease at which blood travels through arteries. For Aim 2, I
hypothesize that load-dependent arterial stiffness will be inversely associated with cerebrovascular
conductance during a dynamic sit-to-stand task, and structural arterial stiffness will be inversely related to
change in brain blood flow amplitude when transitioning from sitting to standing. To test these hypotheses, I
will leverage existing data collected from an ongoing clinical trial in individuals with stroke. I will calculate
carotid and aortic load-dependent and structural arterial stiffness using common carotid ultrasound recordings,
carotid-femoral pulse wave velocity data, and established mathematical modeling. I will use middle cerebral
artery blood flow velocity data, collected using transcranial doppler ultrasound at rest and during a dynamic sit-
to-stand task, to evaluate cerebral blood flow and cerebrovascular conductance. Collectively, these data will
demonstrate how load-dependent and structural arterial stiffness influence resting and dynamic
cerebrovascular blood flow in individuals with stroke. This proposed work will have broad implications for
arterial stiffness and cerebrovascular health post-stroke, contributing to the development of future interventions
which seek to improve arterial stiffness and cerebrovascular health in individuals with stroke.

Public health relevance
PROJECT NARRATIVE Following a stroke, individuals exhibit increased arterial stiffness and reduced cerebral blood flow, which places them at an elevated risk for cerebrovascular decline and recurrent stroke. The proposed research will investigate how arterial stiffness mechanisms, namely load-dependent and structural arterial stiffness, influence resting and dynamic cerebral blood flow in individuals with stroke. This work will therefore provide critical information for the development of future research trials seeking to reduce arterial stiffness and offset the related cerebrovascular decline post-stroke.